The Gut Microbiota and Graft versus Host Disease (GVHD)

Abstract: The Gut Microbiota and Graft-versus-Host Disease
Hematopoietic cell transplantation (HCT) can be lifesaving for the treatment of numerous conditions, including
leukemia, lymphoma, aplastic anemia, multiple myeloma, some immunodeficiencies, and other diseases.
Unfortunately, graft-versus-host disease (GVHD) is a common complication of HCT, affecting up to 50% of
allogeneic transplant recipients, despite human leukocyte antigen (HLA) matching between donor and recipient
and despite use of immunoprophylaxis. GVHD most commonly affects the gut, liver, and skin, producing
diarrhea, liver inflammation, and rashes, with varying stages (degrees) of organ involvement in different
patients. GVHD is thought to arise from immune cells (e.g. T cells) in the graft that recognize host tissues as
foreign and propagate an inflammatory response. It is unclear why some HCT recipients with equivalent HLA
matching develop GVHD while others are spared, and why some patients with GVHD respond to immune
suppression with glucocorticoid treatment while others develop steroid-refractory GVHD with high mortality.
Some murine studies of bone marrow transplantation have shown that germ-free animals are protected from
GHVD, and human studies have suggested that patients with GVHD have a less diverse gut microbiota early
after transplant, pointing to the important role that microbes play in GVHD. This study will investigate which gut
bacterial species or communities are most associated with risk of GVHD in a longitudinal study of HCT
recipients where stool samples are collected weekly for 100 days, then monthly for 9 months, and subjected to
broad-range 16S rRNA gene PCR with high-throughput sequencing for species-level taxonomic identification
of bacteria. Stool samples from these patients will also be assayed for small molecule metabolites produced by
the bacteria-host interaction that may mediate GVHD, such as short chain fatty acids and bile salts. The goal of
this aim is to identify potential chemical effectors of GVHD. Metagenomic sequencing of stool DNA will be used
to assess the functional and metabolic capability of gut bacterial communities to illuminate how particular
bacterial communities produce metabolites linked to GVHD risk, and to identify particular bacterial species or
strains with the metabolic machinery for impacting GVHD risk. Knowledge gained from this study could be
used in the future to design interventions to reduce the risk of GVHD based on targeted manipulation of the gut
microbiota. For example, identification of particular bacterial species or strains linked to protection from GVHD,
and to the production of metabolites that mediate this protection, could lead to the development of probiotics or
engineered bacterial communities for reducing GVHD risk or treating GVHD. Alternatively, enhancing the
production of beneficial metabolites through exogenous administration or use of prebiotics, and blocking the
production of harmful metabolites could emerge as another approach for mitigating GVHD without further
immune suppression in these very compromised patients.

Public health relevance
Project Narrative Hematopoietic cell transplantation is used to treat cancer and other life threatening diseases, but is commonly complicated by graft-versus-host disease (GVHD) that may lead to organ injury, poor quality of life, or death. There is increasing evidence that gut microbes play a role in GVHD, but the precise microbes implicated and the mechanisms responsible are subject to debate. This proposal will help to better define the microbial contribution to GVHD in humans and will explore microbial metabolites as effectors, with the ultimate goal of developing new approaches for the prevention and treatment of GVHD based on manipulation of the microbiota and gut environment.